Effects of xylazine and opioids on prefrontal cortex inhibitory transmission

Xylazine is now highly prevalent in illicit supplies of opioids and poses an emerging threat to public health.
While the compound is used in veterinary medicine for its sedative effects mediated by α2 adrenergic
receptors, little is known about its acute or persistent effects on brain circuits involved in substance use
disorders. This proposal is directly motivated by a recent Notice of Special Interest (NOSI) issued by the
National Institute on Drug Abuse, “Xylazine: Understanding its Use and the Consequences” (NOT-DA-24-
012). The studies outlined in this proposal aim to address the xylazine’s cell signaling profiles and interactions
with opioids at the circuit level. Human studies and preclinical models indicate the prefrontal cortex (PFC) is a
key area involved in affective disturbances, amotivation, and cravings in opioid use disorder (OUD). Opioid
drugs primarily act through the µ opioid receptor (MOR), which reduces feedforward GABA transmission within
the PFC. We provide preliminary data corroborating these findings with the specific MOR agonist DAMGO. By
contrast, the effects of xylazine on PFC function are unknown. We performed analogous electrophysiology
experiments using bath application of xylazine and found a pronounced reduction in inhibitory postsynaptic
currents. Furthermore, we found that xylazine reduces inhibitory transmission within the PFC through the
σ1 receptor, independent from actions at the adrenergic or opioid receptors. In addition, xylazine’s ability to
reduce IPSCs was blunted in slices from mice that underwent oxycodone dependence. Together, these
preliminary findings support the hypothesis that xylazine and opioids synergistically reduce PFC inhibitory
transmission through distinct actions on shared neural circuits. Here, we outline a series of innovative, circuit-
specific electrophysiology experiments to test this hypothesis. Aim 1: Test the hypothesis that xylazine and
opioids exert synergistic effects on PFC inhibitory transmission through distinct molecular
mechanisms. Results from these experiments will determine whether xylazine and opioids exert synergistic
effects and will refine our understanding of xylazine’s cell signaling actions under neurotypical conditions and
following opioid dependence. Aim 2: Test the hypothesis that xylazine and opioids inhibit overlapping
GABAergic circuits. We will leverage the recent development of viral constructs to access and manipulate
MOR-expressing cells (i.e., AAV-mMORp-Cre-mCherry). We will next use a combination of intersectional viral
tools to isolate transmission from MOR-expressing excitatory cells, MOR-expressing inhibitory cells, and MOR-
negative inhibitory cells to define whether xylazine and MOR agonists regulate fast transmission from
overlapping cell types in PFC. Impact: Results from these studies have the potential to be tremendously
influential in how we conceptualize xylazine-opioid co-use. These results could also increase or enthusiasm for
the development of MOR/σ1 bifunctional ligands or σ1 antagonists for the treatment of OUD or pain.

Public health relevance
Project Narrative Xylazine is now highly prevalent in illicit supplies of opioids, but very little is known about its effects on brain circuit function. In this proposal, we aim to understand how xylazine (alone and in combination with opioids) affects neural function and synaptic plasticity within the prefrontal cortex. Results from these studies should influence how we conceptualize the effects of xylazine-opioid co-use and could inform development of novel treatments.